Oscillatory gene expression and the maintenance of temporal patterning

Project Abstract:
Developmental gene regulation is a multidimensional problem where signals converge to generate patterns of
transcription at the proper location (spatial regulation) and correct time (temporal regulation). An equally
important feature of this regulatory process involves generating the correct amount of transcription during
development as many key regulatory genes function in dosage sensitive manners where too much or too little
expression can lead to developmental defects or disease. At present, we have only a primitive understanding
about how the transcriptional output of developmentally regulated genes is established. Experiments outlined in
this proposal aim to directly address this problem by employing an in vivo imaging system in C. elegans larva
where GFP molecules are directly tethered to nascent RNAs while they are being actively transcribed in the
nucleus. This new platform enables us to directly quantify and model the real-time expression dynamics that
ultimately dictate transcriptional output of individual genes throughout development. In Aim 1, we will use this
system to dissect the mechanisms by which two transcription factors, BLMP-1 and LIN-42, modulate features of
transcriptional bursting (including burst frequency, duration, and amplitude) to tune transcriptional levels of key
microRNAs (including lin-4 and let-7) that dictate sequential patterns of cell fate specification. We will then probe
the genomic and molecular mechanisms that BLMP-1 employs to prime future transcription by remodeling
chromatin accessibility near target gene loci. In the final Aim, we will characterize the physical and functional
interactions between LIN-42 and several conserved nuclear hormone receptors (NHR-23RORγ and NHR-85Rev-
erbβ) that mediate temporal aspects of lin-4 and let-7 transcriptional activation. This avenue of research will reveal
the principles by which chromatin remodeling and its impact on modulating the transcriptional output of cyclically
expressed genes ensures the precision and robustness of cell fate specification during development.

Public health relevance
Project Narrative: While precise tuning of gene expression levels is critical for most developmental pathways, the mechanisms by which the transcriptional output of dosage-sensitive molecules is established remain poorly understood. Experiments outlined in this proposal aim to combine the genetic tractability of C. elegans and a novel imaging approach to directly determine how transcriptional dynamics are tuned to generate precise phenotypic outcomes. Specifically, these studies will determine the molecular mechanisms by which two transcription factors, BLMP-1 and LIN-42, modulate aspects of transcriptional bursting to determine the expression levels of key miRNAs that dictate temporal cell fate specification during post-embryonic development.